Comparing epigenetic, proteomic, and MRI aging clocks in sporadic and autosomal-dominant Alzheimer disease

PROJECT SUMMARY/ABSTRACT
While older age is the greatest known risk factor for Alzheimer disease (AD), it is not causative. Increased risk
of AD is likely driven in part by cumulative, progressive physiological processes across biological levels,
termed biological aging. Biological age can be estimated through machine learning-based “clock” models using
rich, multivariate physiological signatures, including DNA methylation (epigenetic age), protein concentration
(proteomic age), and brain structure (brain-predicted age). By characterizing biological age at the epigenetic,
proteomic, and endophenotypic layers, these clocks may detect complementary signatures of biological aging,
which could identify unique processes of AD progression or resilience. The proposed K01 research study will
rigorously compare state-of-the-art biological age clocks across epigenetic, proteomic, and neuroimaging
modalities using available, deeply-phenotyped, longitudinal human AD datasets.
The study will test whether epigenetic, proteomic, and brain-predicted age clocks represent complementary
signatures of biological aging, disease progression, and resilience in sporadic late onset AD (sLOAD), which is
the most common form of AD (Aim 1), and in autosomal dominant AD (ADAD), in which the accelerated aging
hypothesis can be tested with minimal age-related confounding factors (Aim 2). The final aim will test whether
biological age estimates from these clocks differ between sLOAD and ADAD (Aim 3). As protein expression
inherently links genetic and phenotypic layers, we predict that proteomic age will mediate the association
between epigenetic and brain-predicted age clocks in both sLOAD and ADAD. If these multimodal clocks
capture complementary signals of AD risk and resilience, we predict that each clock will explain unique related
variance in both sLOAD and ADAD. If pathological severity is greater in ADAD than sLOAD, we predict that
age clocks will exhibit greater sensitivity to ADAD than sLOAD. This study will address an important knowledge
gap on whether multimodal age clocks provide additive measures of AD staging or resilience. Future
independent research projects may explore multimodal biological age longitudinally, in relation to additional
pathological, risk, and resilience factors, or using more advanced modeling approaches.
This K01 award will support the candidate’s transition towards an independent career with a unique,
transdisciplinary research program in aging, AD, and AD-related dementias (ADRD). A carefully-tailored
training plan will build upon the candidate’s established expertise in cognitive psychology, neuroimaging, and
machine learning with additional expertise in the analysis and interpretation of epigenetic (Goal 1) and
proteomic datasets (Goal 2), frameworks of resilience and protective factors in AD (Goal 3), and development
of the professional skills required to lead and support an independent research lab (Goal 4). These training
goals will be supported by individualized mentorship from a team of domain experts, didactic coursework,
practical skill-building, and completion of the research aims.

Public health relevance
PROJECT NARRATIVE This study will rigorously compare three state-of-the-art models of biological aging across multiple modalities, including DNA methylation, proteomics, and MRI, and will test the novel hypothesis that these measures capture complementary signals of biological aging in relation to Alzheimer disease (AD) progression and resilience. These hypotheses will be tested in both typical sporadic late-onset AD and autosomal dominant AD, a familial, early-onset form of AD, which allows for the evaluation of accelerated biological aging with minimal age-related confounds. Successful completion of the project will address whether multimodal measures of biological age hold translational utility as complementary biomarkers in AD staging or precision medicine estimates of resilience, while also providing the candidate with invaluable opportunities for training in novel, complementary research and professional skill sets.